AG Bell Virtual Global Listening and Spoken Language Symposia and Fall Forums 2025-2029

AG Bell’s annual AG Bell Global Listening and Spoken Language Symposium in 2025 through 2029 will each
include four keynote presentations that focus on the sharing of high-impact research that will impart a fuller
understanding of specific issues related to childhood hearing loss and practical applications. In addition to its
annual symposia, AG Bell plans to initiate a new annual offering, the AG Bell Fall Forum beginning in 2025 to
be continued through 2029. The primary goal of each offering type (symposia, fall forum) is to inform
researchers, clinicians, other professionals, family members, individuals who are deaf or hard of hearing and
other stakeholders of the benefits of various interventions to improve outcomes related to hearing loss such as
auditory function, receptive and expressive speech and language, cognition, literacy, social and emotional
development, education, family function and health and well-being.
Specific aims for the symposia and fall forums include:
1) To provide clinicians/researchers and students with clinically and educationally-relevant research in oral
(presentations) and written (digital proceedings) forms that are applicable to immediate and future
interventions that impact outcomes for children who are deaf or hard of hearing through four keynote
presentations in an annual virtual two-day symposium.
2) To provide the AG Bell national and international community and the general public with the opportunity to
learn about evidence-based “hot topics” in the field through participation in a three-hour annual virtual AG
Bell Fall Forum in the PATH learning management system AG Bell uses for the symposium. This content will
be provided at a level that is targeted to an eclectic audience of parents, individuals who are deaf or hard of
hearing and professionals who conduct research and provide services. Pre-reading materials will be provided to
attendees. Each fall forum will be designed to optimize opportunities for discussion between the presenter and
attendees regarding presented research that will lead to “take-away” applications to future research and clinical
and educational settings.
The five symposia will include keynote presenters who will present (their) research on the following diverse
topics, all of which are related and impactful to children who are deaf or hard of hearing, their families, and the
professionals who work with them:
2025: 1) Predicting spoken language development in the context of parent-child interaction; 2) Disparities in
treatment and outcomes; 3) Long-term communication outcomes in children with cochlear implants who
received them younger than age 12 months; 4) Early language and literacy acquisition; 2026: 1) Acoustic
hearing preservation after cochlear implantation; 2) Literacy development of preschoolers; 3) Treating the
whole child: when it’s more than hearing; 4) Using a national child hearing outcomes registry to help children
reach their best potential; 2027: 1) Considerations of spiral ganglion health: from genomics to gene therapy; 2)
The impact of auditory access on the development of speech perception; 3) Early language learning in children
with cochlear implants; 4) Predictors of vocabulary outcomes in children from Spanish-speaking families;
2028: 1) Non-syndromic hearing loss (like GJB2): where are we now and what does the future look like?; 2)
The impact of early auditory experiences on behavioral and neural outcomes of children; 3) Development of
sensitivity to acoustic modulation in infants who use cochlear implants; 4) Factors associated with reading
comprehension in adolescents; 2029: 1) Considerations when working with children with syndromic hearing
loss (e.g., Usher, Pendred, Waardenburg) d) Predictors of listening-related fatigue in adolescent hearing loss;
3) Emotional regulation; 4) Vestibular and balance function
Each of five fall forums will feature extended learning on hot topics in hearing loss. These forums will include
relevant recent research, evidence-based practices, information on innovative projects or trials, known and
potential impacts on children and their families, and relevance to both the professionals who provide care and
education to them, and those who conduct research. Registrants will be provided with pre-reading materials
prior to a three-hour fall forum related to the hot topic chosen within each of the following content areas and
will be invited to participate in interactive discussion with presenters:
2025: Audiology 2026: Gene Therapy 2027: Family Support 2028: Mild to Severe Hearing Loss 2029:
Cochlear Implants

Public health relevance
Hearing loss and deafness are global health issues affecting over 466 million people, including 34 million children. Professionals and families urgently need access to up-to-date information, medical advances, and new technologies, as lack of these resources hinders language development. AG Bell global symposia and fall forums provide professionals with the latest knowledge, fostering discussions and sharing research to better support children and their families in listening and spoken language development.